Identification of components and mechanisms regulating expanded CUG-repeat RNP complexes in Myotonic Dystrophy Type 1 muscle cells

Project Summary
Myotonic dystrophy (DM) is the most common cause of adult-onset muscular dystrophy and the second most
common cause of muscular dystrophy overall. Myotonic dystrophy type 1 (DM1) results from an expanded
CTG repeat in the 3’ untranslated region of the DMPK gene. The molecular basis for pathogenesis is a toxic
gain of function of the RNA transcribed from the mutant allele that contains long tracts of expanded CUG
repeats (CUGexp RNA). CUGexp RNA remains in the nucleus bound with proteins to form ribonucleoprotein
complexes (RNPs) detected as foci by RNA fluorescence in situ hybridization. CUGexp RNPs include the
Muscleblind-Like (MBNL) paralogs, MBNL1 and MBNL2, that are sequestered resulting in their loss of function
and a primary cause of pathogenesis. CUGexp RNPs are dynamic nuclear structures that are the cause and
therapeutic target of DM1 pathogenesis yet knowledge of the composition of the CUGexp RNP is limited and a
full accounting of the mechanisms of CUGexp RNA toxicity in skeletal muscle remains to be established. To
gain insight into the molecular and cellular biology of CUGexp RNA and the CUGexp RNP in skeletal muscle,
we will use proximity labeling to identify protein and RNA components of the CUGexp RNP complex in addition
to MBNL and CUGexp RNA and determine their roles in CUGexp RNA pathogenesis in skeletal muscle. The
results will provide the foundation to identify novel therapeutic targets and enhance the efficiency of current
approaches targeting the CUGexp RNA component of the RNP.

Public health relevance
Project Narrative The molecular cause of myotonic dystrophy type 1 is known to be a toxic expanded CUG-repeat RNA (CUGexp RNA) that forms ribonucleoproteins (RNPs) that localize in nuclei of skeletal muscle myofibers. The nature of the CUGexp RNP is poorly characterized. The goal of this project is to use proximity labeling to identify the protein and RNA components that contribute to the complex dynamics of the CUGexp RNA RNP and the pathological impact on skeletal muscle.